Molecular Mechanisms Drive Metabolic and Lipid Profiles that Define Cells in the Latent and Lytic Stages of Viral Infection

SUMMARY
Metabolic modulation is critical to maintaining cellular homeostasis and viability throughout the life of a cell.
However, there is a fundamental gap in knowledge regarding the molecular mechanisms that drive and rewire
metabolic pathways in response to cellular perturbations such as viral infection. Viruses commandeer and
manipulate basic cellular biology to persist and reproduce. Long-term viral persistence (latent stage) and active
reproduction (lytic stage) depend on different alterations in fundamental cellular mechanisms, making a viral-
host cell model system ideal to investigate how cellular metabolism is rewired to maintain cellular homeostasis.
Work proposed in this MIRA ESI application will leverage our in vitro model system of herpesvirus infection that
models both latent and lytic infection to define novel cellular mechanisms by which cells in the latent and lytic
stages control metabolic regulation. The overall objective is to conduct an integrative analysis of the metabolic,
lipid, and transcriptional profiles that define how latent and lytic stages of herpesvirus infection have evolved to
maintain metabolic homeostasis. My central hypothesis is that specific metabolic signatures distinguish cell
subpopulations that display differential survival between long-term latent stages and the acute lytic stages of
infection. The rationale for this proposal is that the molecular and cellular mechanisms that are responsible for
controlling metabolic changes during the progression of viral infections remain undefined. Based on preliminary
data and established tools from our research team and established collaborations, I will test my central
hypothesis by pursuing three major questions in the laboratory: (1) Which alterations in central carbon
metabolism define the heterogenous cell populations in the latent and lytic stages? (2) What are the lipid profiles
of heterogeneous subpopulations in the latent and lytic stages? and (3) How do cells in the latent and lytic stages
modify their transcriptional profiles in each subpopulation to control metabolism? By answering these major
questions, my team expects to identify previously unknown alterations in fundamental cellular biology and
uncover novel mechanisms of cellular metabolic control. The research proposed for each research question will
use technically innovative methods including mass spectrometry imaging (MSI) analysis for spatial
metabolomics and spatial lipidomics, single-cell RNA sequencing, and spatial RNA sequencing to define the
transcriptional profile across heterogenous cell populations. Our research will advance our understanding of the
control of fundamental cellular metabolic pathways using a model of herpesvirus infection which allows us to pin-
point specific alterations in carbon utilization. Results from our research will inform the development of future
interventions, thus advancing the NIGMS mission to support biomedical research that increases our
understanding of cellular processes and lays the foundation for advances in disease diagnosis, treatment, and
prevention.

Public health relevance
NARRATIVE Cellular metabolism encompasses several diverse pathways that are responsible for the production of both energy and biosynthetic intermediates throughout the life of a cell. This MIRA ESI proposes innovative systems- level approaches, followed by rigorous mechanistic validation, to determine how cells control metabolism under diverse perturbations, specifically viral infection. In alignment with the NIGMS mission, identifying key molecular pathways that rewire cellular metabolism and maintain cellular homeostasis upon both long-term and acute viral perturbation is expected to contribute to the future development and improvement of interventions that will advance treatment and prevention of disease.